2020 Nanoscale Science and Engineering for Agriculture and Food Systems Gordon Research Conference and Gordon Research Seminar

Project Summary The objectives of this GRC are: 1) To bring together experts and stakeholders to discuss nanotechnology advances, directions, and needs in food and agriculture; 2) To identify cutting-edge research and emerging opportunities to address global challenges of food security, environmental sustainability, food safety, and agricultural productivity. A major goal of this GRC is to promote exceptional early career and female investigators, as well as those of traditionally underrepresented populations, to ensure the continued growth in diversity of scholars in our vibrant community. A diverse range of invited speakers and discussion leaders will present a comprehensive vision of critical and emerging nanotechnology research advances across the field of agricultural science. The program illustrates a targeted excellent diversity of leadership (6), speakers (23), and discussion leaders (11) across the spectrum of: i) gender diversity (19 females, 21 males); ii) USA (24) /International participation (16), representing Austria, Brazil, Canada, Colombia, Denmark, Germany, India, Italy, Korea, Singapore, Spain, Switzerland, and Taiwan; and iii) industry and government (3), which includes the FDA, FAO, a founder of a blockchain startup company, and senior research scientist at a non-governmental organization. The following topics will be included in the program: Food and nutrition, bioinspired and targeted technologies, sensing and tracking, microbiomes, food contact materials and human health and disease. Discussions on the safe deployment of nanotechnology in these areas, public perception and policy, and influence on industry and entrepreneurship are integral to this GRC. The Center for Food Safety and Applied Nutrition (CFSAN), the FDA center responsible for protecting the health of US consumers, will find the following sessions of great interest, Convergence of Nanotechnology with Food & Agriculture; Advances in Nanomaterials; Environmental Nanotechnology; Nano-enabled Approaches to Improving Human & Animal Health; Translation of Nano-Based Science for Application in Food & Agriculture; Big Data, Machine Learning, AI & Modeling; and Nanotechnology's Impact on Food Safety. The significant contributions of this diverse population will provide the strong intellectual infrastructure required to develop safe and sustainable nano-enabled applications in food and agriculture in direct support of the FDA CFSAN goal of ensuring the safety, security, sanitation, and proper labeling of the U.S. food supply.

Public health relevance
Project Narrative Nanomaterials and nanotechnology are rapidly entering almost every industry around the world. The co-chairs of this GRC envision that the convergence between nanotechnology, biotechnology and information science within plant science, animal science, crop and food science/technology and environmental science will lead to revolutionary advances in improving public health. The successful achievement of this lofty vision requires the profound intellectual commitment of scientists and engineers in a highly integrated engagement across numerous disciplines. Some success examples with a focus on nanotechnology in food include: nano- biosensors for identification of pathogens, toxins and bacteria in foods; identification systems for tracking animal and plant materials from origination to consumption; development of nanotechnology-based foods with lower calories and with less fat, salt and sugar, while retaining flavor and texture; integrated systems for sensing, monitoring and active response intervention for plant and animal production; “smart field systems” to detect, locate, report and direct application of water; precision and controlled release of fertilizers and pesticides; development of plants that exhibit drought resistance and tolerance to salt and excess moisture; and nanoscale films for food packaging and contact materials that extend shelf life, retain quality, and reduce cooling requirements. Overall, nanoscale science and engineering has an important role in creating a safer and more productive agriculture and food system. Commercial advances and technological impacts have been limited somewhat due to the relative “newness” of nanotechnology in agriculture and food systems. Given that research at the nanoscale in agriculture and food systems is only into its second decade, safety of nano-enabled applications in agriculture are still up for debate. The Center for Food Safety and Applied Nutrition (CFSAN), the FDA center responsible for protecting the health of US consumers, will find the following sessions of great interest, Convergence of Nanotechnology with Food & Agriculture; Advances in Nanomaterials; Environmental Nanotechnology; Nano-enabled Approaches to Improving Human & Animal Health; Translation of Nano-Based Science for Application in Food & Agriculture; Big Data, Machine Learning, AI & Modeling; and Nanotechnology's Impact on Food Safety. In the spirit of the GRC mission, the 2020 Nano Ag & Food GRC and GRS will again bring together a diverse array of scientists and engineers, both senior and junior, postdocs, and graduate students from academia, as well as scientists and engineers from business, government, and Non-governmental organizations (NGOs); with an emphasis to attract researchers from around the world to engage in open scientific exchange. The significant contributions of this diverse population will provide the strong intellectual infrastructure required to develop safe and sustainable nano-enabled applications in food and agriculture in direct support of the FDA CFSAN goal of ensuring the safety, security, sanitation, and proper labeling of the U.S. food supply.